Auditory nerve central synaptopathy during noise-induced hearing loss

PROJECT SUMMARY/ABSTRACT Sound information is transmitted from the peripheral cochlea to the central auditory system via two key synapses, including the cochlear synapse and auditory nerve (AN) synapse, which are the peripheral and central endings of the spiral ganglion neurons (SGNs), respectively. Selective cochlear synaptopathy among different subtypes of SGNs has been recognized as a main mechanism of hearing loss, one of the most common forms of which is noise-induced hearing loss (NIHL). Cochlear synapses from SGNs of the low spontaneous rate/high threshold subtype are especially vulnerable and can be preferentially damaged by even moderate noise insult, which are likely the primary cause of the perceptual deficit, especially during hidden hearing loss. At the SGN central endings, however, the mechanisms of NIHL remain largely unclear. Little is known about how AN synapses from different subtypes of SGNs change in morphology and physiology during NIHL, and how such central synaptopathy contributes to the central processing deficits in target neurons in the cochlear nucleus (CN). The long-term goal of this project is to elucidate the mechanisms of NIHL at different subtypes of AN synapses and their target CN neurons. Our overall hypothesis is that AN synapses from different subtypes of SGNs have unique synaptic properties, target distinct populations of CN neurons that are dedicated to processing different aspects of sound information, and subject to different levels of synaptopathy during NIHL that lead to distinctive central auditory processing deficits among associated CN neurons. Combining electrophysiology with immunohistochemistry using transgenic mice, this project investigates selective synaptopathy at different subtypes of AN synapses during NIHL, as well as the associated central processing deficits in their target CN neurons. In Aim1, we will identify AN central synaptopathy both morphologically and physiologically at the giant endbulb of Held synapses from three subtypes of type I SGNs after two different levels of noise damage. In Aim 2, we will elucidate the mechanisms of central processing deficits in CN bushy neurons following selective AN synaptopathy during NIHL. In Aim 3, we will elucidate the mechanisms of NIHL in CN inhibitory neural network by characterizing synaptopathy of AN bouton synapses onto D-stellate neurons and clarifying the changes of their output inhibition onto CN bushy neurons during NIHL, especially hidden hearing loss. The outcome of the project will fill our knowledge gap on AN central synaptopathy as well as the mechanisms of central processing deficits in target CN neurons during NIHL.

Public health relevance
PROJECT NARRATIVE Noise-induced hearing loss (NIHL) is one of the most prevalent hearing conditions that affect the general public. Transmission of auditory information is selectively compromised in different subtypes of spiral ganglion neurons (SGN) during NIHL. The pathophysiology has been well characterized at the peripheral terminals of the SGNs (the cochlear synapses), but is less clear at the SGN central terminals (auditory nerve synapses) that transmit all sound information to the neurons in the cochlear nucleus. This project investigates SGN central synaptopathy at different subtypes of auditory nerve synapses during NIHL, as well as the mechanisms of signal processing in their target neurons in the cochlear nucleus. Knowledge gained from this research will not only help us better understand how sound information is transmitted from the ear to the brain and elucidate the pathological changes after noise damage, but also provide guidance and new strategies to optimize clinical interventions in treating NIHL and other hearing impairments.